CALIFORNIA PRIMATE RESEARCH CENTER

The center's research program will primarily relate to selected human-health problems for which the nonhuman is the animal model of choice. The major program units will be in Developmental and Reproductive Biology (emphasis on normal prenatal development, teratological pharmacology); Fetal and Neonatal Medicine (emphasis on perinatal host defense mechanisms); Respiratory Diseases (emphasis on the effects of environmental oxidants) and Pathobiology (research programs in hepatic pathophysiology; behavioral biology; immunodeficiency; comparative genetics; and a variety of biomedical collaborative research projects. A major theme of the CPRC encompasses the adverse effects of environmental factors on vertebrate organisms and the recognition and development of new spontaneous and experimental-induced disorders. Research Resources is a large support unit composed of teams of specialists responsible for the high quality of animal care and ensures the humane handling of the animals. Special attention will continue to be given to the discovery of new spontaneously occurring animal models within the colony which will serve as models for human diseases.